A biochemical roadmap of exercise signal

PROJECT SUMMARY
Exercise is an effective intervention for both the prevention and treatment of cardiometabolic diseases, but the
mechanistic underpinnings of the health benefits of exercise remain incompletely defined. Recent work
highlights the importance of inter-organ circuits in mediating healthful exercise responses. We identified β-
aminoisobutyric acid (BAIBA) as a novel small molecule “myokine” that increases the expression of brown
adipocyte-specific genes in vitro and improves glucose disposal and decreases weight gain in mice. In
humans, plasma BAIBA concentrations are increased with chronic exercise and demonstrate a strong inverse
association with metabolic risk factors. Further, related efforts by our group have positioned us as leaders in
characterizing within- and between-tissue molecular responses to exercise and dietary interventions.
These experiences, coupled with the high translational relevance of the research problem, motivated our
participation in the MoTrPAC initiative. Our team was built upon existing collaborations between Duke, Harvard
and the Broad Institute with complementary strengths in metabolomics and proteomics technologies and
decades of experience in cardiometabolic research. To date, we have provided a deep menu of analytical tools
for targeted and non-targeted metabolomics, protein profiling, and the analysis of key protein post-translational
modifications. Group members have been deeply involved in the animal and pre-COVID biochemical profiling
efforts, in collaborations with other Chemical Analysis Sites (CAS) and the Bioinformatics Core to harmonize
workflows, and in the working groups necessary to integrate the data. We have also played key roles in
associated scholarly activities and in developing the next generation of translational investigators focused on
exercise science.
An additional distinction of our team is the ability to integrate new findings from MoTrPAC with ongoing
genomic, proteomic and metabolomic analyses in large human cohorts and other exercise studies led by our
investigators. We hypothesize that integrating the metabolomic and proteomic profiles of human tissues and
blood during exercise with genetics and detailed human phenotyping will provide novel insights into the
interorgan circuits and within-organ responses that mediate its salutary effects. We are deeply committed to
the notion that all data generated by this multi-disciplinary consortium will be made rapidly available to the
scientific community.

Public health relevance
PROJECT NARRATIVE Exercise is an effective intervention for both the prevention and treatment of heart and metabolic diseases. Our goal is to understand the fundamental mechanisms by which exercise confers its healthful benefits. A better understanding of exercise may identify those individuals who are most likely to derive benefit from intensive interventions or novel therapies to improve human health and longevity.